Enhancing Diversity and Addressing Disparities at the 7th Cancer Cachexia Conference

ABSTRACT
This proposal requests partial support for the 7th Cancer Cachexia Conference organized by the Cancer
Cachexia Society (CCS), to be held from September 28-30, 2023, in Edinburgh, Scotland. This iteration of the
conference follows prior events in Boston, Montreal, Washington DC, Philadelphia, and two virtual versions
during COVID. The long-term goal of the conference series is to foster research, awareness, and understanding
of cancer cachexia among scientists, clinicians, patients, and caregivers, for the purpose of advancing
identification, treatment, and cure for this major unmet medical need. Indeed, cachexia causes considerable
patient and family distress and is estimated to cause some 30% of cancer deaths; yet until recently, cachexia
was seldom addressed in any of the major cancer meetings. This conference series has served to help grow
awareness and research around cancer cachexia and remains the only one devoted solely to this topic. Research
in cancer cachexia is small relative to all cancer research and is global, with roughly equivalent research activity
in North America, Europe, and Asia and notable efforts in Brazil and Australia. Hence, we have opted to hold the
7th conference in Scotland to facilitate international access and collaboration. The Aims of the 7th Cancer
Cachexia Conference are to: 1 - Deliver a rich scientific program for participants while promoting networking and
new collaborations. 2- Promote interaction among patients, caregivers, providers, and investigators and develop
enduring patient-facing educational material. 3- Provide for training and mentorship of graduate students,
postdoctoral associates, and junior faculty. 4-Expand and grow diversity, equity, and inclusion in the conference
and the wider field of cancer cachexia research. The impact of this conference will be to promote progress and
growth in the clinical investigation of anti-cachexia therapies and to strengthen knowledge, research, and
research capacity in cancer cachexia.

Public health relevance
NARRATIVE The Cancer Cachexia Conference is the only conference series dedicated to the tumor-induced condition known as cachexia, which is unintentional loss of body weight and muscle mass in cancer. Cachexia is responsible for 30% of cancer deaths and there is no effective treatment due to low research activity and resources. The Conference convenes leading experts in the basic, translational, and clinical science of cachexia in order to find treatment, and includes patient-caregiver sessions to foster shared understanding among patients, family members, clinicians, and scientists.